Sleep and Cardiometabolic Health Disparities at the US/Mexico Border: The Nogales Cardiometabolic Health and Sleep (NoCHeS) Study

ABSTRACT
Short sleep duration, insomnia disorder, and sleep apnea are all highly prevalent in the US population and are
associated with significant morbidity, including poor mental health, impaired neurocognitive function, metabolic
dysregulation, and cardiovascular disease. In the context of the high prevalence of pernicious sleep
disturbances, there is evidence that sleep disparities exist in the population, such that racial/ethnic minorities –
including Mexican-Americans – are at increased risk of sleep disturbances. This is alarming, since this group is
also at increased risk for many of the adverse cardiometabolic and functional outcomes linked to sleep
disturbances. These associations may be influenced by economic hardship, psychosocial stress, unhealthy
behaviors (diet, exercise, alcohol, and smoking), and acculturation – the degree to which an individual adopts
(in this case) traditional Mexican versus American culture. The first goal of this project is to examine sleep
duration, insomnia symptoms, and sleep apnea severity among Mexican-Americans and examine the role of
these social-behavioral factors in this relationship. Second, this study aims to examine the role of sleep and
cardiometabolic disease risk in this population and explore the role of acculturation, psychosocial stress,
economic hardship, and/or unhealthy behaviors in these associations. To accomplish this, this project will
partner with the Mariposa Community Health Center, the federally qualified clinic in the Nogales, AZ area.
Nogales is a small city on the US/Mexico border that is an ideal location for studying non-urban Mexican-
Americans, as it is made up of 83% Hispanics/Latinos, 33% immigrants, and 77% who primarily speak Spanish
at home. This community-engaged project will partner with Mariposa and their Platicamos Salud program that
uses experienced Community Health Workers (promotoras de salud) to collect data and perform home visits.
The study will recruit N=900 Mexican-Americans and N=200 Non-Hispanic Whites to complete a battery of
assessments from a clinic visit (questionnaires, interviews, exam for anthropometry and arterial stiffness, and
collection of biomarkers), a 1-night home sleep apnea assessment, a 24-hour ambulatory blood pressure
recording, and a 2-week home monitoring period with sleep diary and actigraphy. This will result in a rich dataset
that can help to identify and reduce sleep disparities in the population and point to potential intervention
approaches to reducing cardiometabolic disease disparities. The analytic plan will take advantage of a
machine-learning analytic approach, which will be used to evaluate the complex relationships among all of
these variables. This project will address many relevant issues in sleep medicine, health disparities research,
and border health. The partnership with Mariposa will enhance recruitment, promote research integrity (or ensure
appropriateness of research methods), and facilitate dissemination of the study results into the community
through education programs associated with Platicamos Salud and other community outreach efforts.

Public health relevance
PROJECT NARRATIVE The primary goal of this study is to assess sleep health among Mexican-Americans at the US/Mexico border, characterize relationships with cardiometabolic disease risk, and investigate the role of social-environmental factors including acculturation, stress, socioeconomics, and health behaviors. Short sleep duration, insomnia disorder, and sleep apnea are highly prevalent in the population. These conditions are associated with cardiovascular disease, diabetes, daytime functioning problems, and poor mental health. Disparities in sleep health in racial/ethnic minorities exist, including Mexican-Americans. In particular, social-environmental factors at the US-Mexico border may play an important role in sleep health disparities. This project will not only allow for increased understanding of the complex relationship among sleep, health, and social-environmental pressures, but through a community partnership it can maximize our ability to reduce these disparities. Also, this project has the added benefit of providing information about the role of sleep as a potentially modifiable factor in cardiovascular disease and diabetes disparities as well.